Patient Oriented Research in Vulnerable Populations with Skin Disease

PROJECT SUMMARY/ ABSTRACT
This application proposes a renewal of a Mid-career Investigator Award in Patient-Oriented research for Eleni Linos, MD DrPH, Professor of Dermatology at Stanford University. Dr. Linos’ long term career objectives are to perform rigorous research to improve the care of patients with skin disease. This renewed award will build on her previous work and accomplish the following objectives: to expand her current research portfolio to the care of elderly patients with skin disease, and the disease area of Hidradenitis Suppurativa.
The mentorship goals of this renewal proposal are aligned with the research aims. The proposed studies provide hands-on research training experiences in quantitative and qualitative data collection and analysis for mentees, and will produce preliminary data for mentees' K, T, and R applications.
The research aims will provide additional opportunities for mentees to develop skills in machine learning, large language models, quantitative and qualitative research, biomedical ethics, health disparities research and a new focus area of Hidradenitis Suppurativa. The new projects build directly on her previous research and leverage existing networks, collaborations and access to leaders in behavioral science and geriatrics, social media and technology.
Aim 1: To describe the progression of Hidradenitis Suppurativa using a longitudinal image library from patients of all skin types.
Aim 2: To describe the mental health, sleep, and quality of life burden of Hidradenitis Suppurativa.
Aim 3: To identify barriers and solutions to the implementation of digital tools in the dermatologic care of patients from all backgrounds.
This award will ensure that Dr. Linos has sufficient protected time to fully support her mentees. The long-term goal of this research is to expand knowledge on the care of patients with skin disease, in order to improve the quality of life and optimize dermatologic care of these patients. This K24 renewal award will provide Dr. Linos with the opportunity to expand her mentoring and research on these topics and allow her to train the next generation of dermatologic researchers so that they are equipped to improve the lives of patients with skin disease and build the research workforce of the future.
Together, the Research Plan and Mentoring Plan provide a new five-year strategy that is directly relevant to the NIH and NIAMS missions of training the next generation of physician scientists to carry out patient-oriented research.

Public health relevance
PROJECT NARRATIVE The purpose of this proposed renewal of a K24 Midcareer Investigator Award is to mentor the next generation of patient-oriented researchers focused on improving the care of patients with skin disease. The mentorship goals of this proposal are aligned with the research aims. We will use novel machine learning, quantitative and qualitative methods in order to highlight opportunities for improved care for patients with Hidradenitis Suppurativa and older adults with skin disease.